Early intervention to prevent development of PTSD in burn survivors and their caregivers

Project Summary
In this K23 proposal, I detail a 4-year training plan to launch my independent clinical research career focused on
mechanism-based early interventions to prevent PTSD and enhance health in traumatic injury patients and their
caregivers. Through the rich training environments at the University of Southern California and National Center
for PTSD, and the committed mentorship of my exemplary multidisciplinary team comprised of Dr. Haig
Yenikomshian (primary), Dr. Denise Sloan (co-mentor), Dr. Johanna Thompson-Hollands (co-mentor), and Dr.
Katherine Ehrlich (advisor), I will achieve training in 1) mechanism-based PTSD clinical trial research for acute
care interventions, 2) implementation barriers and facilitators with medical, hospital, patient, and caregiver
stakeholders, 3) advanced statistical analysis techniques for longitudinal data, 4) inflammatory biomarkers, and
5) professional competencies essential for independence. PTSD impacts approximately 1 in 3 traumatically
injured hospitalized burn patients, a rate 3-4x that of the general population. Burns disproportionately impact
marginalized and minoritized individuals/families with social and economic insecurities that lead to barriers in
access to outpatient mental healthcare, highlighting the importance of early intervention during acute
hospitalization. However, there are no validated interventions for hospitalized injury patients at risk for PTSD.
The proposed study will adapt and test a brief patient-caregiver early intervention (PoED) associated with
reduction of PTSS in discharged emergency department patients and extend it to hospitalized burn patients at
risk for PTSD and their caregivers (PoED-B). PoED-B is a cognitive-behavioral dyadic intervention that targets
reduction of dyadic social constraints (e.g., invalidating, negative statements) and avoidant coping by teaching
dyads to engage in adaptive natural disclosures, supportive responses, and approach coping after the burn
trauma using psychoeducation, motivational interviewing, and skills coaching. After refinement through
stakeholder interviews and a case series (n=4, 2 dyads), we will conduct a small randomized clinical trial (n=40;
20 dyads) comparing PoED-B to a minimally enhanced usual care psychoeducation control (mEUC). The primary
aim is to take an experimental therapeutics approach to demonstrate that PoED-B is feasible, acceptable, and
engages the target of reduced social constraining behaviors in dyads relative to mEUC. A preliminary
examination will also be conducted of the estimated effects of PoED-B vs mEUC and variability in patient-
caregiver social constraints on PTSS improvement, relationship quality, and later PTSD diagnosis. An
exploratory aim is to examine the impact of change in social constraints on PTSS and inflammatory biomarkers
as theorized mechanisms of change in PoED-B. This early intervention trial aligns with NIMH Strategies 3 “Strive
for Prevention and Cures” and 4 “Advance Mental Health Services to Strengthen Public Health” and has the
potential to mitigate early risk for postinjury PTSD, reduce symptom burden, and improve overall health in a
historically underserved comorbid mental health and medical population.

Public health relevance
Project Narrative This research aims to prevent PTSD in traumatic injury patients and their caregivers, addressing a critical public health issue that affects one in three hospitalized burn patients. By developing and testing an early dyadic intervention for burn survivors and their caregivers that targets social constraining behaviors, the study seeks to enhance mental health outcomes and facilitate recovery in a vulnerable population. Ultimately, this work could lead to more effective interventions, reduce the burden of PTSD, and improve overall health and quality of life for those impacted by traumatic injuries.